Augmented Reality Platform for Feedback and Assessment in STEM elementary education

ABSTRACT This SBIR Phase I project will build evidence-based content, challenges and assessments that promote: simulation-based learning; troubleshooting and critical-thinking; and diversity and inclusion in STEM learning. The approach will be transferable by design to teaching and measuring learner performance across scientific disciplines. Emerging digital content in virtual (VR) and augmented reality (AR) is already transforming science, technology, engineering, and math (STEM) education from the abstract and static learning models of the past to the applied and dynamic learning experiences of the future. These technologies have promise in delivering simulation environments capable of nurturing deep learning and higher-level thinking in K-12 students through practical experience, hand-on exercises and real-life applications, such as troubleshooting. Digital AR and VR educational content is beginning to address and develop these skills, but a platform has yet to be developed to effectively enable broad adoption in elementary settings. Cost efficient methods to provide formative feedback and gather summative evaluations for Next Generation Science Standards (NGSS) is also an unmet need. The successful completion of the proposed project will provide an evidence-centered content delivery and assessment framework as well as tool for addressing NGSS performance expectations that is transferable across topic areas and readily scalable for large-scale national implementation. The content will intentionally incorporate aspects of context and diversity of characters to ensure inclusion of groups that are historically underrepresented ? specifically females and ethnic minorities.

Public health relevance
NARRATIVE Success in the workforce of the future will require the high-level thinking skills that the Next Generation Science Standards (NGSS) emphasize. Emerging digital content in virtual (VR) and augmented reality (AR) is transforming science and engineering education from the abstract and static learning models of the past to the applied and dynamic learning experiences of the future, through practical simulation-based experiences, but these lack the capability for performance assessment crucial to teachers and decision makers. By providing a readily scalable and flexible platform, the proposed approach promises to accelerate access to high-quality, inclusive, and evidence-centered AR content delivery and assessment of NGSS standards which in turn provides students with the skills they need for success.